Geroscience Education and Training (GET) Network

Summary
In developing educational materials and meeting with our GET Network advisory committees we
often discuss where the educational boundaries of the GET Network may dovetail with existing
or upcoming training programs in aging (both basic and clinical) and geroscience. For example,
the NIA's Division of Aging Biology recently published an approved concept informed by the
Trans-NIH GeroScience Interest Group (GSIG) to create “short-term educational programs with
a primary focus on courses that enhance and expand Geroscience skills and development at all
levels of professional career development.” This concept is aligned with the mission of the GET
Network, yet independent. Similarly, other NIA-supported R25's (eg, R25AG071488) are also
creating educational content or delivery methods highly relevant to other groups. We hope to
share resources, update on our progress, and get input from a wider group of people working on
similar concepts, as we all have much to learn for long-standing educational programs in aging.
An opportunity presented itself when we were approached by the CEO of GSA, James Appleby,
about disseminating GET Network content and scope at the society's 2022 meeting. During our
discussions, we realized that more than just presenting work completed within the GET
Network, there is a real advantage to engaging with investigators and educators beyond the
GET Network. We are therefore requesting an administrative supplement to support a
preconference workshop at the 2023 GSA meeting to allow us to harmonize with other
educational programs, introduce key concepts for teaching and training programs in
geroscience, and disseminate our work. This is directly aligned with the goals of the GET
Network, but represents additional work beyond what was proposed in the parent award.
We will invite 50 interdisciplinary participants to attend and contribute as speakers and
discussants, including students, early career contributors and key stakeholders. Additionally, we
plan to hold meetings for our Content and Dissemination committee members on the same day.
Finally, three junior faculty or postdocs will be selected to record the discussions and participate
in a separate whitepaper writing retreat to develop a manuscript of the meeting proceedings for
submission to a GSA-affiliated journal.

Public health relevance
Project Abstract Narrative This is an administrative supplement to our funded and in progress project, Geroscience Education and Training Network (GET Network R25AG073119) to support a preconference workshop entitled “Building an Interdisciplinary Workforce in Geroscience” to be held at Gerontological Society of America's 2023 annual scientific meeting. The supplement aligns with and builds on our existing GET Network goals by creating a one-day workshop to convene key stakeholders and persons leading educational and training programs in aging and geroscience.